FOLLOW UP STUDIES ON NEONATES WITH SEX CHROMOSOMAL ABNORMALITIES

The specific aims of this project were to define the cognitive, phsychosocial, and neuroanatomic phenotypes of adults with sex chromosome abnormalities. Specific measures of language and psychosocial function were included, along with magnetic resonance imaging studies of all participants.